Synthetic mesoscope to image large-scale neural activity with near-single-cell resolution in freely-behaving animals

Project Summary
Most, if not all, cognitive functions require the coordination of multiple brain regions. The ability to simultaneously
monitor neural activity across multiple brain regions in cellular resolution and high speed during natural behavior
is important to study how different parts of the brain work together to support behavior. Doing so requires the
recording device to have a high spatiotemporal resolution over a large field of view, and be sufficiently light and
compact so it can remain stable on the animal’s head while the animal freely behaves. Optical methods are
especially promising to fulfill all these requirements. However, existing optical miniaturized microscopes have
tradeoffs among the field of view, resolution, and device footprint. To achieve fine resolutions, most of the existing
miniaturized microscopes can only image a sub-millimeter scale field of view.
We propose to develop a miniaturized imager that can record neuronal activity in near-cellular resolution over
the entire cranium in freely-behaving mice. We have previously demonstrated a miniaturized 3D microscope
where all bulk lenses are replaced by a thin layer of microlens array. The microlens array effectively splits the
entire field of view into different regions, and uses different lens units to image them in parallel. A computational
algorithm is then used to reconstruct and synthesize the 3D volume. This approach enables high-resolution
imaging over a large 3D volume through a thin device. Our microscope achieved <10 µm lateral resolution over
4x6 mm2 field of view, and can reconstruct 3D volume across ~600 µm depth range with ~50 µm axial resolution
from a single 2D captured image. In this project, we will optimize and expand the microlens array so it could
image neural activity across the entire cranium (~9x10 mm2) and 400 µm depth in near-cellular resolution in
freely-behaving mice. We will package the image sensor, microlens array, and illumination optics into a compact
device. We will develop deep-learning-based algorithms that can faithfully reconstruct neuronal activity over the
3D cortical volume from recordings that are highly corrupted by light scattering in real time. Compared to existing
algorithms, our approach can significantly reduce the required computational resources and processing time.
Our miniaturized imager enables the investigation of very large-scale neuronal circuits distributed across the
cortex. We will run testbed experiments on both freely-moving mice and head-unrestrained macaque monkeys,
two important animal models for studying the neural basis of behavior. We will leverage well-established
experimental paradigms, including passive viewing of visual stimuli and navigation in open arenas. These
experiments will serve to validate, benchmark, and further refine our techniques in vivo. The cross-species
experiments will not only prove the potential of our imager, but also provide critical insights into how animal
behavior emerges from the orchestration of individual neurons in large-scale neural circuits. This development
and validation of this new technology will pave the way for many exciting future experiments, and greatly enhance
our ability to address important neuroscience questions that are challenging with the existing techniques.

Public health relevance
Project Narrative We propose to develop a miniaturized imaging device that can record brain activity in high resolution over the cortex in freely-behaving animals. Using this device, we will study how multiple regions of the brain function together in mice during behavioral tasks and how the visual cortex in head-unrestrained macaques mediates visual perception. This new imaging device will enable research on how different brain regions support behavior, and on mechanisms and treatments of various neurological disorders.